Biomedical Informatics, Bioinformatics, and Cyberinfrastructure Enhancement Core

ABSTRACT – BIOMEDICAL INFORMATICS, BIOINFORMATICS, AND CYBERINFRASTRUCTURE
ENHANCEMENT CORE
The successful execution of clinical and translational research relies on coordinated access, curation,
management, preservation, analysis, and dissemination of data, information, and knowledge from many sources
(e.g., academic, health, and government). The long-term goal of the Advance-CTR Biomedical Informatics,
Bioinformatics, and Cyberinfrastructure Enhancement (BIBCE) Core is to transform the environment for clinical
and translational research in Rhode Island by enabling access to electronic health data, providing core
informatics infrastructure, and identifying dissemination, implementation, and improvement strategies to
overcome barriers to adoption of evidence into practice. Core activities are coordinated by the Brown Center for
Biomedical Informatics, along with leadership from Advance-CTR partners (Brown University, The University of
Rhode Island, Lifespan, Care New England, VA Providence Healthcare System, the Rhode Island Department
of Health, and the Rhode Island Quality Institute). Through formal arrangements with our data partners, we have
overcome barriers to accessing and sharing statewide data. The focus of the next phase of the BIBCE Core will
be on establishing scalable resources and services for standardized and integrated access. Regular engagement
of key stakeholders from the academic, health, and government communities has been critical as BIBCE Core
resources and services are further enhanced to promote sustainability. The Core also seeks to train and engage
researchers in best practices for applying resources, knowledge, and skills to support data- and technology-
driven projects across the spectrum of basic, clinical, and population science. The mission of the BIBCE Core is
thus to advance use of data and technology to support the full spectrum of clinical and translational research.
The Specific Aims are to: (1) Promote a sustainable and extensible informatics infrastructure to support the
diversity of clinical and translational research needs; (2) Develop innovative data, software, and technology
solutions in collaboration with clinical and translational researchers; and, (3) Provide state-of-the-art informatics
training and engagement with clinical and translational research stakeholders. The BIBCE Core capitalizes on
the diverse population of Rhode Island to disseminate, implement, and improve solutions that are relevant to our
local community, and still be scaled nationally. Metrics for success to transform and invigorate clinical and
translational research are aligned with national standards for evaluation as defined by the biomedical informatics
community. Guided by the RE-AIM (Reach, Effectiveness, Adoption, Implementation, and Maintenance)
framework and in collaboration with the Tracking and Evaluation Core, we will evaluate these outcomes, impacts,
and metrics to gauge progress and success in meeting overall Advance-CTR objectives, including for our state’s
health priorities. The continued engagement of Advance-CTR partners with the shared vision of using data and
technology to improve the health of the State’s and regional population will synergistically expand clinical and
translational research opportunities.